Inducible overexpression of ABCA7 in astroglia in vivo as a means to study its function in disease pathogenesis

Abstract
Alzheimer's disease (AD) dementia is a major burden on the healthcare system and a major barrier to human
longevity, especially productive human longevity. Genetics of familial early-onset AD, pathological changes in
the brain of sporadic late-onset AD patients and pathological changes in the brain of individuals with Down
syndrome, who have increased expression of amyloid precursor protein (APP) owing to partial trisomy of
chromosome 21, all point to APP and its cleavage product amyloid β (Aβ) peptide as causative factors in the
pathogenesis of AD. Adenosine triphosphate-binding cassette transporter subfamily A member 7 (ABCA7) is
also a major factor in AD pathogenesis that bears on Aβ metabolism. Unfortunately, the mechanisms of its
effect on Aβ turnover and the disease progression have been uncovered insufficiently. One reason for this is
that the currently commonly-used Abca7 deletion mouse model have yielded divergent and contradictory
findings and may not be suitable for the discovery of ABCA7 functions. We summarize the finding made with
the model and point to the weaknesses of this model. Given this, we propose to make a tissue-specific ABCA7
overexpression mouse using the Cre/loxP system. An overexpression model will have several advantages as
an ABCA7 investigation tool over the deletion model. It is then proposed to use the overexpression model to
test a hypothesis about the role of ABCA7 in astrocytes, in particular that astrocyte ABCA7 drives production of
apolipoprotein E-lipoprotein and thus promotes efflux of the neurodegenerative lipid from the cells and
clearance of Aβ from the brain. We have recently proposed the existence of the neurodegenerative lipid
generated during normal functioning of neural tissue. The proposed model will be valuable for the studies of
ABCA7 in the neural tissues, while the proposed experiment will advance our understanding ABCA7 functions.

Public health relevance
Project Narrative Adenosine triphosphate-binding cassette transporter subfamily A member 7 (ABCA7) significantly bears on the risk of Alzheimer's disease by a poorly understood mechanism. The present project entails making a mouse model of inducible expression of the human ABCA7. This model will facilitate the studies into the mechanism of neuroprotective activity by ABCA7 and will be useful for preclinical work to assess feasibility of ABCA7 as a target of therapy for Alzheimer's disease.